Nanoporous semiconductor-enabled multi-site photostimulation for cardiac resynchronization therapy

Project Summary
A wide range of deformable biointerface devices are employed for the diagnosis, treatment, and monitoring
of cardiovascular diseases by measuring physiological parameters, applying bioelectrical modulation, or
delivering drugs. Despite preclinical advances in biotechnology such as optogenetics and cell-based biological
pacing, non-genetic electronic methods remain the dominant method for treating cardiac rhythm disorders.
Semiconductors, in particular, have emerged as a potentially useful tool for non-genetic cardiovascular research,
including field effect transistor-based electrophysiology sensing, light-driven cardiac population activation, and
electronics-integrated cardiac tissue engineering.
We recently published several photoelectrochemical methods for optically modulating cardiac activity in
cultured cells as well as in adult rodent models ex vivo. The use of light to modulate cardiac tissue with an
intensity comparable to that used in optogenetics has been demonstrated. In this work, Tian will work closely
with Hibino to expand and strengthen our newest photoelectrochemical biomodulation system, porosity-based
silicon heterojunctions, for multi-site, leadless, nongenetic, and optoelectronic modulation of cardiac tissues.
Specifically, we will design, construct, and test a selection of heterojunctions based on porosity for optical
modulation of cardiac tissues. We will synthesize core/shell nanowires, core/shell microparticles, and bilayer
membranes that contain non-porous/nanoporous heterojunctions. To improve the stability of the heterojunctions
under physiological conditions, we will apply atomic layer deposition to passivate the silicon surfaces. We will
modify the material surface with metal or metal-oxide catalysts to enhance signal transduction. To support the
silicon heterojunctions, we plan to use soft matrices such as polymers and hydrogels, which will enhance
biocompatibility and signal transduction at the biointerfaces. We will also fabricate biocompatible optical fibers
for use in in vivo photostimulation experiments. In order to enable multi-site optical pacing, we will develop,
assemble, and test the software, mechanical, electrical, and optical components. Afterwards, we plan to validate
the scanner's performance, such as its accuracy, scanning speed, and power delivery, followed by the
photostimulation tests ex vivo. The device will then be tested to determine its biocompatibility in a rat model,
followed by testing heart pacing in acute and chronic settings using single-chamber, dual-chamber, and multi-
site stimulations in a pig model. We will test our hypothesis that deformable and biocompatible heterojunction
devices can be used for multi-site cardiac resynchronization therapy triggered by optical signals.
The proposed research can define a new treatment option for cardiac modulation. Incorporating freestanding
and photosensitive semiconductors with excitable cells and tissues will result in biointerfaces that can be
controlled by light. The new designs for semiconductor-based biointerfaces would allow for wireless, nongenetic,
multiscale, and random access photomodulation.

Public health relevance
Project Narrative We propose a class of porosity-based silicon heterojunctions for multi-site, leadless, non-genetic, and optoelectronic modulation of the heart. These studies will accelerate progress in understanding and treating abnormalities in the electrical conduction systems of the heart in vivo.